Regulation of Microbial Trafficking to the Thymus in Early Life

Project Summary
Early life is a critical period for the proper development of the immune system. As mammalian hosts have co-
evolved with their symbiotic bacteria, signals from the commensal microbiota are crucial for the prevention of
allergy, inflammatory disorders, and protection against enteric pathogens. Our lab has recently uncovered that
commensal antigens are trafficked to the thymus by dendritic cells, where they are presented to developing
thymocytes. Rather than inducing deletion or Treg development, this results in an expansion of naïve microbiota-
specific T cell populations, which are functional and egress to populate the peripheral tissue. This process is
limited to early life, suggesting that it is critical for the establishment of the commensal-reactive T cell repertoire.
Analysis of thymic 16S sequencing from mice at weaning reveals a stark enrichment of select taxa, such as
members of Escherichia. When considering the vast diversity of the intestinal microbiome, these data imply an
antigenic filter through which only select microbes are trafficked to the thymus. This proposal seeks to understand
how the unique environment of the early-life intestine promotes commensal ferrying to the thymus, and the
microbial and host factors that curate specific taxa for sampling by sub-epithelial dendritic cells. My central
hypothesis is that this process has evolved to prioritize the generation of naïve T cell clones capable of
recognizing antigens associated with epithelial invasion. We posit that the signals promoting commensal antigen
trafficking to the thymus are 1) adherence to the intestinal epithelium and 2) opsonization by maternal IgG. As
recent publications have identified commensal-specific IgG as targeting microbes with the ability to translocate,
both of these signals indicate the capacity for epithelial invasion – whether defined by the neonate or by maternal
cues. Preliminary data indicate that non-adherent commensals are significantly underrepresented in the thymic
tissue. I have also found increased expression of the IgG receptor FcRn in migratory thymic DCs in early life,
indicating their enhanced ability to recognize and process IgG-opsonized commensals. In Aim 1, I will quantify
the epithelial adherence of a model commensal E. coli throughout early development. I will genetically target
adhesins in this commensal to determine how these factors impact epithelial adherence and thymic trafficking in
vivo. I will utilize 16S sequencing to compare the mucosa-associated microbiome with that of the thymus. Aim 2
will focus on the role of maternal IgG opsonization, and will quantify thymic trafficking in B cell- and antibody-
deficient mouse models throughout early life development. I will manipulate maternal IgG titers through transfer
of commensal-specific IgG into IgG-deficient dams, and the impacts on thymic trafficking in offspring will be
examined. The proposed experiments will reveal crucial elements of how the commensal-reactive T cell
repertoire is curated in early life, and will have important insight into how the microbiome affects the development
of the mucosal immune system.

Public health relevance
Project Narrative A subset of commensal microbial antigens is trafficked to the thymus in early life and presented to developing thymocytes to expand microbiota-specific T cells. This proposal seeks to identify the microbial and immunological signals that promote microbe trafficking to the thymus during this developmental ‘window of opportunity’ and provide insight into the establishment of the commensal-reactive T cell repertoire. As microbe-specific T cells are implicated in protection against enteric infections, and the pathology underlying Inflammatory Bowel Disease, this project will advance our understanding of how the microbiome influences the development of the mucosal immune system.